Stanford PRIHSM: PReventing Inequities in Hemorrhage-related Severe Maternal Morbidity

Project Summary: Overall
Postpartum hemorrhage (PPH) is a leading cause of maternal death and severe maternal morbidity (SMM) and
disproportionately affects socially marginalized groups. We propose to create a Maternal Health Research
Center of Excellence at Stanford University called PRIHSM (PReventing Inequities in Hemorrhage-related
Severe Maternal morbidity). The goals of PRIHSM are to reduce PPH and associated SMM by reducing
antenatal iron deficiency anemia (IDA), addressing disparities in rates of cesarean birth and cesarean-linked
PPH, and attending to the impact of PPH on postpartum mental health. IDA affects approximately 16% of
pregnancies in the U.S.; rates are 3-4x higher among Black people and 1.5-2x higher among Latinx people,
compared to the rest of the population. This translates to higher rates of PPH-related SMM. We propose that
by effectively addressing antenatal IDA and these disparities, we can reduce PPH-related SMM. Intrapartum
exposures also play a major role in the risks and disparities associated with PPH. Almost 1 in 3 U.S. births are
by cesarean delivery, rates vary 10-fold across hospitals, and Black and Asian individuals have the highest
prevalence of cesarean section among low-risk pregnancies. We propose that enhanced birth equity and
reduced variability in obstetric management are important strategies in addressing disparities in cesarean-
linked PPH and reducing PPH-related SMM. PPH may also dramatically alter the postpartum emotional life
course. Prospective longitudinal research to understand mental health trajectories following PPH is needed, as
are effective treatments. We propose an approach that is innovative in that it targets the unique clinical and
mental health spectrum of PPH at multiple intervention points, through multi-disciplinary, community-engaged
science. Our Aims are: Aim 1 (Project 1). Reduce antenatal IDA by developing, implementing, and
disseminating a patient-informed Anemia Prevention Toolkit, which will standardize the evaluation, diagnosis,
and treatment of IDA and reduce the prevalence of IDA and racial/ethnic disparities in IDA at birth admission
and PPH-associated SMM. Aim 2 (Project 2). Reduce disparities in rates of primary cesarean birth and
cesarean-linked PPH by conducting a mixed methods study to understand drivers of hospital-level disparities
in these outcomes, and implementing a patient-informed Maternal Equity Guide. Aim 3 (Project 3). Advance
our understanding of PTSS following severe PPH by examining the course of PTSS following PPH, and
implementing patient-informed PTSD treatment and prevention strategies. Our work will involve community-
university partnerships focused on improving maternal health equity and be driven by perspectives of patients,
providers, and healthcare leadership. Our work will provide training opportunities to build research and clinical
expertise relevant to PPH, especially among individuals who represent diverse perspectives and experiences
within academic and community-based settings, and under-served areas. We propose a bold yet achievable
agenda that will affect a sustainable decline in PPH-related mortality and morbidity and disparities.

Public health relevance
Project Narrative: Overall Postpartum hemorrhage (PPH) is a leading cause of maternal death and severe maternal morbidity (SMM) and disproportionately affects socially marginalized groups. The goals of this center are to reduce PPH and associated SMM by targeting important precursors to PPH-related SMM and mortality: cesarean birth and iron deficiency anemia (IDA). We propose a research agenda that includes scalable interventions that will lead to sustainable declines in all of these outcomes and realization of maternal health equity.